Developmental Funds

Our current CCSG provides approximately $130,000 each year in developmental funds. Over the past four years of the CCSG these funds were used for 1) Seed grants with a focus on translational research activities 2) New faculty recruitments with a focus on young investigators 3) New Shared resource (tissue procurement service) 4) Strengthening current Core Resources